In Toto Readout of Transcriptomes and Lineage Relationships in Native Craniofacial Tissues

PROJECT SUMMARY
In response to Notice of Special Interest (NOSI): Single-Cell Level Spatiotemporal Mapping of Dental and
Craniofacial Embryogenesis (NOT-DE-22-003), we propose innovative new technology to comprehensively map
the transcriptomes and lineage histories of all cell types in the vertebrate face, and how these are altered in
congenital anomalies and adult repair. Current lineage tracing techniques lack the ability to define all cell
relationships at single-cell resolution in complex vertebrate tissues such as the face. The cranial neural crest-
derived mesenchyme generates the majority of skeletal and connective tissues of the face, yet we still have an
incomplete picture of the diversity of mesenchymal progenitors, whether there is a hierarchy or continuum of cell
fate decisions, and whether lineages vary across the face to generate diverse structures. To do so requires new
ways to label every cell uniquely and permanently in the developing face, and then to read out shared lineage
histories and cell type information in the context of native tissue. This proposal aims to achieve this through a
cross-disciplinary collaboration between zebrafish (Gage Crump) and mouse (Amy Merrill) craniofacial experts
at the University of Southern California and a systems biologist (Michael Elowitz) at the California Institute of
Technology. As zebrafish and mouse are powerful and complementary models for craniofacial disease research,
we will use seqFISH technology to map the transcriptomes of all cell types of the developing face in both species.
We will then use a new type of MEMOIR lineage barcoding technique developed by PI Elowitz that allows lineage
histories to be read out together with transcriptomes by seqFISH while preserving spatial context. Integration of
seqFISH and MEMOIR will allow us to comprehensively define all craniofacial cell types and their lineage
relatedness from the time of barcoding. Analysis of lineage histories of the normal fish and mouse face will reveal
the types of lineage relationships, how they vary across the face, and the extent to which they are conserved
across vertebrates. Next, we will apply MEMOIR to complementary zebrafish and mouse Nr5a2 mutant models,
which we showed have altered ratios of skeletal and connective tissue types in the jaw. Global analysis of altered
lineage relationships in mutants will reveal the types of lineage decisions controlled by the Nr5a2 nuclear receptor
and the extent to which its role has evolved from fish to mammals. We will also use MEMOIR to understand the
degree to which reprogramming of cell identity may underlie the ability of zebrafish to robustly regenerate bone
and cartilage in the adult jaw. In particular, we will compare the extent to which different injuries induce distinct
types of lineage plasticity to replace the correct missing cell types. In the future, stimulating lineage plasticity in
mammals may represent a novel strategy to boost endogenous repair of non-healing injuries. More broadly, our
project will serve as a paradigm for globally defining lineage relationships in diverse craniofacial tissues in the
context of normal development, genetic disease, and adult repair.

Public health relevance
PROJECT NARRATIVE Development and maintenance of the complex vertebrate head depends on precise regulation of cell fate decisions, particularly in the multipotent neural crest population. We propose to combine innovative genetic barcoding approaches with spatial transcriptomics in zebrafish and mouse to define all cell types and their lineage relationships in the developing vertebrate face. By assessing how cell lineages change in response to genetic mutations and injury, we will better understand the cellular bases of craniofacial congenital anomalies and tissue regeneration.